Immune Monitoring Core

PROJECT SUMMARY/ABSTRACT
Immunotherapy has advanced tremendously in the past decade and cellular products are now being leveraged
efficiently in a number of settings. Third party targeted therapeutic Immune Effector Cell (IEC) interventions are
bound to change the way we treat AML and ALL. NK cell products hold promise because of their ability to quickly
kill tumor cells without causing graft versus host disease (GVHD). Similarly, tolerance inducing regulatory T cells
(Tregs) are a T cell population with cytolytic as well as tolerance induction potential. Furthermore, in the
allogeneic setting, Tregs suppress GVHD and graft rejection. This grant focuses on clinical implementation of
novel Treg and NK targeted therapeutics in AML and ALL, as well as development of novel CAR-iTregs and
CAR-iNKs. An overarching hypothesis of this PPG is that allogeneic Treg and NK cell immunotherapies can be
engineered to maximize successful leukemia control with decreased toxicity, when compared to conventional T
cell immunotherapy approaches. To that end, Core C will provide seamless sample processing and state-of-the-
art assays to best inform the projects on how IEC cell interventions work in the clinic and help assess how novel
IEC products perform pre-clinically. The Core integrates the processing, storage/annotation, distribution, and
analytic capabilities of the Translational Therapy Laboratory, an NCI funded Cancer Center Support Grant
shared resource, with a number of novel techniques to gain deep understanding of Treg and NK cell biology, the
immune landscape influencing and resulting from IEC intervention, and the tumor microenvironment (TME) the
IEC cell interventions must operate in. Mass cytometry, CyTOF, will be used to phenotypically evaluate IEC
products and immune reconstitution at a high level of detail. CyTOF analysis of bone marrow samples will also
be leveraged to evaluate the TME. Cytolytic assays will be used to determine IEC function pre-clinically and after
patient treatment. Assays will be carried out equally across all projects to determine differences in
pharmacokinetic and pharmacodynamic profiles of each of the products so they can be fairly compared to each
other and inform project leaders on how to best implement IEC interventions. Uniform, high-quality data
generated in these studies will be integrated with clinical outcomes, in collaboration with Cores A and B, and
will be made available to all of the projects in order to maximize synergy and limit variation generated by having
different laboratories carry out assays for individual projects.

Public health relevance
PUBLIC HEALTH RELEVANCE This grant focuses on pre-clinical development and clinical implementation of novel third-party Immune Effector Cell (IEC) products in leukemia settings. Core C will serve all of the projects by uniformly integrating sample processing and state-of-the-art analytics for all clinical trials carried out in this grant as well as pre-clinical IEC product evaluation. The resulting high-quality data will be linked to clinical outcomes, in collaboration with Cores A and B, and pre-clinical IEC product functional determination, in collaboration with Core D and Projects, and presented to Project 1, 2, and 3 leaders.